Administrative Core

Abstract: CMITT Administrative Plan
The broad mission of our Center for Molecular Imaging Technology & Translation (CMITT) is to develop, validate
and disseminate cutting-edge imaging technologies that take advantage of the game-changing capabilities afforded
by simultaneous acquisition of PET/MR to yield major improvement in accuracy (sensitivity and specificity) of
characterization of normal function, as well as diagnosis and follow up of disease in the very early stages. The
Administrative Core supports the mission of CIMITT through maintaining efficient management, facilitating
communication among all stakeholders including collaborators and staff, and seeking input from the External
Advisory Committee (EAC) and the Internal Steering Committee (ISC). The Administrative structure includes the
PD/PI and his Deputy Director, as well as the TR&D Project Leaders and the Leader of the Training and
Dissemination Core. Together with the ISC and EAC, they evaluate outside requests for collaborative projects and
service projects and manage the scientific and technological direction CMITT must strategically take. The External
Advisory Committee will meet once a year and provides an outside view on research priorities and plans in the
CMITT. The composition of the Board reflects a mix of locations and professional backgrounds to ensure a thorough
and objective evaluation of activities. The Internal Steering Committee consists of key clinical and research leaders
from the different medical specialties and research areas relevant to CMITT.